Programmed translation arrest controlled by nascent peptides and antibiotics

DESCRIPTION (provided by applicant): ABSTRACT The ribosome can functionally respond to specific nascent peptides. Such response, which can be additionally affected by small molecular weight cofactors, is a key component of the mechanism of control of important bacterial and eukaryotic genes. However, the molecular mechanisms of recognition of the regulatory nascent peptide and cofactor and the basic principles of the ribosomal response are poorly understood. Expression of a number of inducible antibiotic resistance genes in bacterial pathogens is controlled by nascent peptide-dependent programmed translation arrest promoted by antibiotic. Recently, a distinct class of regulatory nascent peptides encoded in the regulatory cistrons of many macrolide resistance genes has been identified. The peptides of this class are characterize dby the presence of an 'RLR' (Arg-Leu-Arg) motif. Preliminary studies showed that the mechanism of programmed translation arrest directed by these peptides is principally different from all of the previously studied systems. Furthermore, nascent peptides as short as three or four amino acids were found to be sufficient to direct drug-dependent ribosome arrest thereby yielding the shortest known stalling peptides. Such minimalistic stalling nascent peptides and the knowledge of the exact binding site of the stalling cofactor (the inducing antibiotic) provide unprecedented tools for unraveling important fundamental aspects of the general mechanisms of nascent peptide- and small cofactor-controlled programmed translation arrest. In the three specific aims of this proposal we will 1) explore the structural features of the minimalist nascent peptide required for directing ribosome stalling, 2) analyze the role of the antibiotic cofactor in programmed translation arrest, and 3) unravel the mechanism of the stalling signal recognition and structural features of the ribosome in the arrested state.

Public health relevance
PUBLIC HEALTH RELEVANCE: PROJECT NARRATIVE One of the major challenges of modern medicine is combating the spread of resistance to antibiotics. Many bacterial pathogens activate expression of the resistance genes in response to the presence of antibiotics. Understanding the molecular mechanisms of inducible resistance will, among other applications, pave the way for novel strategies to develop superior drugs capable of curbing bacterial infections. __SpecificAimsTextDelimiter__ Nascent peptide-controlled translation arrest regulates expression of several important bacterial and eukaryotic genes. This mechanism reflects the fundamental property of the ribosome to modulate its functions according to the structure of the nascent peptide in the exit tunnel. Ribosome stalling often also requires the presence of specific small molecules and thus reveals the ribosome as a sensor of the cell's physiological state. However, the principles of recognition of the nascent peptide and small molecular weight cofactors of stalling remain obscure. The most medically relevant genes controlled by nascent peptide-dependent ribosome stalling are the inducible genes of resistance to macrolide antibiotics. One of the prevalent types of regulatory cistrons at which ribosome stalling takes place encode nascent peptides characterized by the presence of a conserved Arg-Leu-Arg sequence (the 'RLR' peptides). Our preliminary investigation showed that extremely short nascent peptides of this class composed of only three (or possibly four) amino acids can efficiently direct macrolide- dependent translation arrest. The availability of such a short stalling peptide and the knowledge of the precise binding site of the antibiotic molecule that serves as a stalling cofactor offer exceptional opportunities for unraveling the molecular mechanisms of programmed translation arrest. In this proposal, we will investigate the mechanism of the nascent peptide- and antibiotic- dependent ribosome stalling controlled by the minimalist peptide and antibiotic. At the fundamental level, our anticipated results should unravel the basic principles of a potentially broadly used mechanism of translation regulation and ribosomal response to the nascent peptide and small molecules. In practical terms, our study will provide important information about the control of expression of clinically relevant antibiotic resistance genes and may provide new approaches for developing superior antibiotics capable of avoiding the action of inducible resistance genes. In our proposed project we will pursue the following specific aims: Specific aim 1. Elucidate features of the nascent peptide and aminoacyl-tRNA essential for antibiotic- dependent programmed translation arrest. Specific aim 2. Unravel the role of the antibiotic cofactor in ribosome stalling with the 'RLR' nascent peptides Specific aim 3. Identify the ribosomal sensors of the stalling signal and elucidate the structure of the arrested ribosome.